Integrated high-throughput functional assays to identify ulcerative colitis causal risk variants

SUMMARY
Ulcerative colitis (UC) affects over 1 million people worldwide. Relative risk is increased by >13.8 fold for close
relatives of affected individuals. Genome-wide association studies (GWAS), including a meta-analysis lead by
Co-I Cho, have identified 133 UC- or shared Crohn’s Disease (CD)/UC-associated loci. Due to haplotype
structure, GWAS usually nominate clusters of large numbers of single nucleotide polymorphisms (SNPs) in
linkage disequilibrium (LD), making it difficult to distinguish causal vs neutral flanking SNPs in LD.
Furthermore, most of these SNPs are in non-coding regions, making functional interpretation even more
difficult due to incomplete knowledge of non-coding regulatory elements. Here, we test the hypothesis that
genetic risk to UC is mediated through colon-intrinsic mechanisms. The overall goal of this study is to rationally
select the causal UC-associated non-coding and coding variants active in normal colon epithelial cells. We
have computationally identified 1,407 GWAS UC-associated non-coding variants mapping to
enhancer/promoter regions active in the colon, and 248 GWAS UC-associated missense variants. In Aim 1,
we will experimentally examine each of the 1,407 candidate non-coding SNPs in colon organoids through an
innovative high-throughput mutagenesis transcriptional readout pipeline integrating a novel massively parallel
chromosome-integrated self-transcribing active regulatory region sequencing assay (iSTARR-seq) with the
high-throughput quantitative dual luciferase assay to nominate causal UC non-coding risk variants. In Aim 2,
we will experimentally examine each of the 248 candidate missense SNPs through our INtegrated PrOtein
INteractome perTurbation screening (InPOINT) pipeline combining six high-throughput mutagenesis functional
assays to quantify the impact of coding variants on protein stability and specific protein-protein interactions.
Based on our experimental results, we will perform integrated network analysis to nominate 10 causal variant
candidates (7 non-coding and 3 coding variants) for functional evaluation in vivo using CRISPR/Cas9 genome
editing in colon organoids in Aim 3. Successful completion of these aims will provide important insights into the
genetic mechanisms driving Ulcerative Colitis and establish a strategy broadly applicable for identifying causal
variants underlying complex traits for other diseases.

Public health relevance
NARRATIVE Ulcerative colitis (UC), which affects over 1 million people worldwide, is caused in part by genetic changes inherited from one's parents. Here, we propose to take advantage of novel, massively parallel experimental approaches we have developed to screen through genetic changes statistically associated with UC to identify those changes most likely to directly cause the disease and then test these candidates in more complex biological models. Our study will not only provide important genetic insights into UC for diagnosis and treatment development, but also establish a strategy broadly applicable to other complex genetic diseases.